Research Training Program in Diabetes and Obesity

Project Summary
The Indiana University Diabetes and Obesity Training Program began in 1999 and has
been funded for fifteen years by NIDDK, currently at the level of two pre-doctoral and
two post-doctoral trainees. The goal of the program is to provide training to young
researchers at an early career stage of their careers, in research that is relevant to
diabetes, metabolism, and obesity, an ever growing problem for the health of the nation.
The Indiana University School of Medicine is an outstanding forum for such an initiative.
Twenty three faculty from six departments will participate as mentors in the program.
This group of faculty has a strong training record and has $7.2M of direct external
funding as PIs, with $2.5M of this from NIDDK R-grants, JDRF and ADA. In addition, the
group has $2.9M of U and P grant support from NIDDK. For the upcoming cycle,
support for two pre- and two post-doctoral trainees is requested as well as four summer
medical students. Pre-doctoral students will take a Minor in Diabetes and Obesity which
includes a 2 credit Diabetes and Obesity course. Post-doctoral fellows will also take the
course. Both students and post-doctoral fellows will attend Center for Diabetes and
Metabolic Diseases seminars, will present their results in the same series, and will be
encouraged to present their work at national meetings such as the American Diabetes
Association scientific sessions. Additionally, they will take a Research Ethics course, a
course on Scientific Rigor, and a Grant Writing Workshop. The program is sensitive to
the issue of diversity and in the past funding cycle four out of fourteen trainees were
URM. By training in an environment and culture that gives strong multi-disciplinary
support for diabetes research, there is a significant probability that the trainees will
sustain an interest in diabetes, even as their specific research interests evolve over their
careers.

Public health relevance
Project narrative Diabetes mellitus is one of the predominant causes of premature loss of life in the United States and other developed countries - the incidence of type 2, as well as type 1, diabetes is on the increase to the extent that diabetes has become one of the major health concerns in the United States. The problem of diabetes and obesity is widely reported by the popular press and other media outlets. It is important to provide training in the area of diabetes research with the objective of increasing the number of young researchers committed to careers confronting this common disease.